Innate immune response signaling in cardiac injury healing

Abstract
Myocardial infarction (MI) due to underlying atherosclerosis is the leading disease
sequela that precipitates heart failure in the Western world. Our ability to treat these
patients and their heart failure has not progressed beyond a mild 20-30% extension in
life span realized some 3 decades ago with neuroendocrine-based management [1].
New therapeutic avenues are needed, the most dramatic of which would be directly
generating new cardiomyocyte to regenerate the damaged area of heart tissue.
Previous attempts to regenerate the heart through new myocyte production have not
been successful despite more than 18 years of research using adult progenitor cells.
However, studies with cardiac progenitor cells in rodent models did show a functional
benefit to the MI-injured heart, although we now understand that this is not due to
significant new myocyte production. Instead we and others have identified a novel
mechanism of benefit whereby injected progenitor cells have a rejuvenating effect on the
MI-injured heart through refinement of the immune response. Indeed, we have shown
that cell therapy injections that flank the recently injured area of the heart from ischemia-
reperfusion (7 days later) can optimize healing, reduce infarct area expansion and
augment scar borderzone physical properties (Vagnozzi et al., 2020, Nature). These
beneficial effects were mediated through selective macrophage subtype activity in the
heart, underscoring the importance of the immune response in cardiovascular health and
infarct healing and compensation. Here we propose the hypothesis that selective innate
immune response signaling pathways, and macrophage subtype polarization can be
exploited to help heal the heart. Our more specific hypothesis is that therapy has an
underlying protective component through Toll-like receptor (TLR) signaling in both
cardiomyocytes and macrophages, and this can be therapeutically exploited to polarize
the immune response for better healing. The specific aims are: AIM #1, To examine the
mechanism of innate immune signaling in the heart through TLR signaling. AIM #2, To
inducibly alter macrophage subtypes in the heart to reprogram the innate immune
response and healing dynamics by cell therapy. AIM #3, To determine how fibroblasts
communicate with macrophage subtypes in the post-MI injured heart to affect healing
dynamics by cell therapy. Such studies will be critical for examining how innate immune
signaling at the level of macrophages and cardiomyocytes impacts the heart during an
inflammatory injury response with the goal of modifying this response to benefit cardiac
healing in patients.

Public health relevance
Relevance The relevance of this application is rooted in the fundamental translational biology of how the immune system impacts cardiac disease presentation and resolution. It is very important to understand and define the basic science mechanisms underlying how the adult human heart heals after ischemic injury and how the immune system intimately regulates this process. Here we will attempt to define therapeutic applications for directly altering the immune response in the heart during and after injury.